Macrophage targeted microparticles for the regeneration of atrophied muscle

PROJECT SUMMARY: Muscle weakness in VA patients most commonly results from inactivity related to injury,
illness, or surgery. Even with aggressive rehabilitation, bouts of enforced skeletal muscle inactivity can lead to
atrophy and loss of function that persist long after remobilization. While pharmacotherapies might improve
outcomes for many veterans suffering from loss of function secondary to disuse atrophy, none exist. Since age-
related loss of muscle function accelerates further loss of function and increases risk of disability, development
of a pharmacotherapy that enables full recovery of function would be transformative for veterans and the general
population. Effective recovery of atrophied skeletal muscle is dependent upon macrophages. First, macrophage
inflammation directs satellite cells to fuse with damaged fibers to facilitate repair. Then, macrophage regenerative
factors resolve inflammation and promote muscle growth. Therefore, a pharmacotherapy is needed that can
specifically target these cells within the skeletal muscle. We met this challenge by developing polymer particles
for localized, extended release of all-trans retinoic acid (ATRA-PLG). ATRA is in broad use clinically for
indications other than muscle wasting, but our data indicate delivery of ATRA-PLG to the facia of atrophied
muscle restores muscle fiber size, improves mobility, increases IGF-1, and decreases IL-6 in the early phase of
recovery. Also, in vitro studies indicate ATRA-PLG induces macrophages to secrete IGF-1. Therefore, our central
hypothesis is that administration of ATRA-PLG to atrophied muscle enhances 1) skeletal muscle recovery and
2) the macrophage regenerative response. We will test this hypothesis by inducing muscle atrophy with cast
immobilization in mice and then injecting ATRA-PLG with release kinetics that match the time course of muscle
recovery when the cast is removed. Specific Aim 1 will determine if ATRA-PLG delivery accelerates functional
recovery of skeletal muscle after remobilization. Specific Aim 2 will determine if ATRA-PLG delivery enhances
the macrophage regenerative response in skeletal muscle recovering from disuse. The potential of this work for
positive impact is high. A pharmacotherapy that enables full functional recovery of atrophied muscle could
revolutionize healthcare for veterans and the general population. If we are successful in rodents, the pathway to
clinical implementation is clear and straight forward. First, our therapy could be tested in large animals using
ultrasound-guided delivery, which is already used in humans for localized musculoskeletal interventions. Second,
ATRA is one of the most prescribed medications in the U.S. and PLG is implemented in 19 FDA drug
formulations. Thus, if ATRA-PLG is successful, getting this therapy to veterans may be faster and less expensive
than developing new drugs. Finally, the delivery system is versatile, able to accommodate new or additional
pharmaceutics or multiple administrations, if necessary. Given that the investigative team has the required
expertise in muscle physiology, regenerative immunology, and drug delivery to carry out the proposed work, we
are confident that the project will bring us closer to realizing a pharmacotherapy for veterans struggling to achieve
full function after prolonged immobility.

Public health relevance
When mobility is limited, such as during severe illness or injury, muscles undergo a rapid loss in mass referred to as disuse atrophy. Atrophy decreases muscle strength and hinders the patient’s ability to rehabilitate, leading to functional disability which is exacerbated in aged populations. We are developing biodegradable, biocompatible particles for delivery to atrophied muscle. The particles are designed to promote the release of biomolecules that enhance muscle metabolism and growth. This innovative approach complements current rehabilitation strategies (e.g. physical therapy, nutritional support) and is expected to maximize functional recovery in aged patients, a population that struggles to recover from muscle atrophy secondary to disuse.